Dynamic Regulation of Erythropoietin Gene Expression in Mammals.

Anemia is a common medical condition associated with significant morbidity and mortality,
especially if present with other diseases such as heart failure. The development of recombinant
Erythropoietin (Epo), a pro-erythrocyte hormone produced in adult kidney and liver during anemia,
revolutionized anemia treatment. Unfortunately, non-physiological bolus Epo administration also
promotes thrombosis, hypertension, and possibly cancer growth. This occurs in part because
administration of exogenous Epo lacks the normal feedback regulatory features of endogenous Epo,
which is rapidly down-regulated even before erythrocytosis is evident. Endogenous Epo production and
iron uptake are tightly controlled by the stress-responsive, heterodimeric transcription factor Hypoxia
Inducible Factor 2 (HIF-2), whose actions are regulated by oxygen-dependent and oxygen-independent
post-translational modifications (PTM). The oxygen-dependent PTM include hydroxylation of prolyl
residues in specific elements of the HIF alpha proteins mediated by oxygen-dependent prolyl
hydroxylases (PHD), a family of three related proteins that exhibit differential recognition of HIF-1 and
HIF-2 alpha subunits.
Development of PHD inhibitors (PHDi) have recently come to market after a concerted
development effort over nearly two decades, but their long-term safety remains unknown. The
mechanism of action for PHDi involves stabilization and/or enhanced activity of HIF-2 signaling.
However, HIF-1 signaling is likely activated as well given the lack of complete specificity for the PHDi
as well as cross-talk that PHD proteins have for HIF themselves. Although PHDi may represent an
improvement over exogenous bolus Epo administration, PHDi treatment must still be tightly controlled
as they also lack feedback behaviors associated with control of endogenous Epo production.
Furthermore, because these agents have only recently come to the market and are being used in select
regions of the world, side effects associated with their use in real world settings are only now coming to
light. There have been case reports of increased thrombosis with their use and there is at least a
theoretical concern for development of iron overload, given that prolonged augmentation of HIF-2
signaling in the gut may also stimulate iron uptake and utilization.
In order to leverage the normal feedback regulatory features of Epo expression, we must
understand how HIF-2 signaling occurs in a dynamic and temporal sense during hypoxia. One
mechanism for enhancing HIF-2 signaling involves cyclical acetylation and deacetylation post-
translational modifications. A rate-limiting step in this process is provision of acetyl CoA for use in
acetylation of HIF-2, which is generated by the acetate-dependent acetyl CoA generator, acyl CoA
synthetase 2 (Acss2). Acss2 is active in the early phase of hypoxia when cells generate acetate in
response to this environmental stress. In this proposal, we will define the interactome surrounding
Acss2 and HIF-2 under normoxic conditions as well as under early and late hypoxia periods. We will
also determine if a rational drug therapy approach, based upon the knowledge of how HIF-2
acetylation/deacetylation is accomplished, can be used to treat mice with chronic anemia associated
with chronic kidney disease.

Public health relevance
Several prevalent diseases in Veterans result in reduced oxygen content, or hypoxia, in vital organs of the body. These include anemia, heart disease, stroke, kidney disease, cancer, amongst others. Every cell in the body has the capacity to turn on genes and proteins in response to hypoxia in an attempt to counter the damage that otherwise results. In some cases, this hypoxia response is beneficial; in other cases, it exacerbates the disease. This proposal seeks to understand how the hypoxia response is controlled. The Potential Impact on Veterans Health Care based upon information gained from these studies is development of targeted treatments that enhance or repress the hypoxia response.